Alterations and Renovations

PROJECT SUMMARY/ABSTRACT ALTERATIONS AND RENOVATIONS SD BRIN has five predominantly undergraduate institutional (PUI) partners with various levels of research cultures on their campuses. SD BRIN has initiated the campus research cultures and continues to maintain and strengthen biomedical research projects for both the PUI faculty and their students. Many partners offer undergraduate research experiences during the academic year as part of course work or independently and all offer the SD BRIN summer undergraduate fellows program for exposing students to cutting-edge research. The Alterations and Renovations funds offered with every phase of INBRE have been used by the PUI partners to remodel and improve their research spaces. SD BRIN routinely offers the partners the opportunity to apply for $125,000 for upcoming A&R needs. During the first phase, Black Hills State University used the money for remodeling to move the core facility into a new building while Mt. Marty College used the money to convert old library spaces into science laboratories with enhanced electrical power. During the second phase, Augustana used the money to improve the animal facilities and other shared equipment spaces in the large addition to the science building that they were building, while University of Sioux Falls used the money for remodeling laboratory spaces for safety in their new science building. During this phase, Mt. Marty is planning to convert two classrooms into dedicated office and laboratory spaces for the new exercise physiology and nursing research laboratories. Dakota Wesleyan University is launching a new building to house a new School of Innovation and Leadership and will use the money to convert one of the spaces into an Innovation Lab for the sciences to be used for independent student research projects. Since A&R is hard to come by for any institution, SD BRIN has tried to be fair by sharing the funds among the partner institutions as needed.